Research Experience and Training Coordination Core (RETCC)

CORE D (RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE): SUMMARY
Trainees are critical to achieving the overall goals of the Berkeley SRP Center related to our central theme:
“Systems approach to address the complex problems associated with Superfund contaminants”. Trainee
research—in environmental health, environmental science, environmental engineering, and data science—will
help to quantify perinatal and childhood exposures; protect disadvantaged communities from exposures;
understand the totality of chemicals to which communities are exposed; account for interactions among
mixtures of chemicals at hazardous waste sites and in health impact assessment; and develop novel chemical-
biological approaches to remediate chemicals in situ and persistent chemicals resistant to traditional methods.
To best address these complex problems, the objectives of the Research Experience and Training
Coordination Core (RETCC, Core D) are to recruit Trainees with diverse backgrounds, perspectives and skills
(Aim 1); foster cross-disciplinary fluency and training and interdisciplinary research opportunities within the
Berkeley SRP, and among West-Coast SRP Centers, to address real-world problems (Aim 2); coordinate
opportunities for trainee participation in research translation and community engagement training and activities
(Aim 3); provide professional development training and opportunities to develop skills needed to participate in,
and lead, multidisciplinary teams to address complex environmental problems (Aim 4); and, evaluate training
activities and provide information on trainee accomplishments to the SRP (Aim 5). Through interaction with all
other Cores and research Projects, RETCC will provide all trainees with a holistic training experience to
increase understanding and engagement in the overall goals and SRP mandates, foster interdisciplinary skills
and mindset, and increase social and cultural awareness of the affected communities in the context of SRP
and California’s Human Right to Water Law. We will leverage campus resources and the expertise of SRP
faculty, alumni, and stakeholders to provide a unique and dynamic curriculum that includes bi-weekly seminars
and workshops on a range of topics related to Berkeley SRP goals, hands-on training, projects, and cross-
mentoring, interdisciplinary classes such as Health Risk Assessment, Green Chemistry and Riskscapes and
Environmental Justice. We will promote and support hands-on activities such as planning a virtual forum to
foster interdisciplinary research among Centers; the preparation of outreach materials and videos; engagement
with stakeholders and communities on projects; networking with alumni and professionals in a wide range of
related fields; and leadership in NIEHS’s SPAN and other organizations. We will encourage our trainees to
participate in the NIEHS Annual Meeting and other meetings and to apply for honors and awards including the
SRP KC Donnelly Externship Program, SRP Karen Wetterhahn Memorial Award and the Berkeley Big Data
Fellowship. We anticipate recruiting 27 trainees: 12 postdocs (2.5 years); 6 MS students (2 years); and 9 PhD
students (4-5 years) and our goal is to double the percentage of URM Trainees to 18% (5 Trainees).

Public health relevance
CORE D (RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE): NARRATIVE Berkeley SRP Trainees are critical to achieving the goals related to the central theme of our Center: “Systems approach to address the complex problems associated with Superfund contaminants.” These complex problems require diverse perspectives and skills; cross-disciplinary knowledge and interdisciplinary research to provide relevant knowledge and tools to reduce contamination and adverse health effects; and communication and leadership skills to work in multidisciplinary teams and with diverse communities and stakeholders to effect regulatory and policy change. The Research Experience and Training Coordination Core (RETCC) will recruit Trainees from diverse backgrounds, provide a holistic training experience beyond each trainee’s main field of focus or expertise to increase trainee understanding and engagement, foster interdisciplinary skills and mindset, increase social and cultural awareness, and strengthen professional development and career skills to address current problems and prepare future leaders in environmental health science and engineering.